Discovery, Replication, and Validation of Biomarkers of the DASH Diet and Hypertension

ABSTRACT
Preclinical and observational evidence supports a cardioprotective role of vitamin D. However,
vitamin D supplementation in randomized controlled trials has failed to reduce cardiovascular events
or cardiovascular mortality. Characterizing metabolites and proteins associated with vitamin D
supplementation, assessing their associations with cardiovascular disease, and examining sources of
heterogeneity may help to elucidate mechanisms underlying the epidemiological associations and
yield insights into the discrepant null findings in clinical trials. While serum 25(OH)D is commonly
measured to assess vitamin D status and its association with disease outcomes, it does not directly
reflect biologically available vitamin D or its functions in the body. High-throughput technologies can
identify thousands of metabolites and proteins in blood and urine, which may provide a more
comprehensive understanding of vitamin D metabolism than serum 25(OH)D. We propose to
investigate novel biomarkers of vitamin D supplementation in the Atherosclerosis Risk in
Communities Study (ARIC) using untargeted metabolomic and proteomics, as well as examine
prospective associations between vitamin D-related metabolites and proteins with cardiovascular
outcomes. This cost-effective proposal leverages existing omics data in a richly phenotyped cohort of
black and white older adults with validated cardiovascular outcomes. Untargeted metabolomics of
both serum and urine, and untargeted plasma proteomics, have already been analyzed using
specimens collected at ARIC visit 5. Our multi-omic approach maximizes opportunities for biomarker
discovery, as well as exploration of how these biomarkers vary according to participant characteristics
including sex, race, and body mass index. The study team is led by an R01-funded investigator with
extensive experience analyzing metabolomics and proteomics of dietary exposures and chronic
disease outcomes. The proposed research will advance knowledge of vitamin D metabolism and
characterize pathways through which vitamin D supplementation may promote cardiovascular health.

Public health relevance
NARRATIVE While serum 25(OH)D concentrations are associated with cardiovascular health in observational studies, vitamin D supplementation has not reduced cardiovascular disease risk in clinical trials. The proposed research will investigate novel biomarkers of vitamin D intake in order to elucidate metabolic pathways linking vitamin D status to cardiovascular disease.